BMP SIGNALLING IN EYE AND KIDNEY DEVELOPMENT

DESCRIPTION: Experiments are designed to gain further insight into BMP signalling pathways during organogenesis. Aim 1 is to evaluate contributions of BMP7 to cell proliferation, survival, and programmed cell death during eye and kidney development. Aim 2 is to describe further the ability of BMP7 to regulate inductive tissue interactions during eye and kidney development. Aim 3 is to examine potentially distinct and overlapping functional roles of divergent BMP family members during eye and kidney development.